Regional differences in guideline-concordant cancer care and outcomes among American Indian Alaska Native people

ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
24-032. American Indian and Alaska Native (AIAN) people experience a disparate burden of cancer than their
non-Indigenous counterparts. Critically, substantial differences in cancer burden exist across AIAN groups.
Receipt of timely and evidence-based guideline concordant cancer treatment contribute to survival disparities
affecting AIAN people. Survival is lower among AIAN people not receiving guideline-concordant cancer care;
however, when AIAN people do receive guideline-concordant treatment, cancer-specific survival does not differ
from that observed among NHW. Yet, little is known about variation in guideline-concordant care by region
among AIAN people, or about differences in receipt of guideline concordant care between people living in
Purchased/Referred Care Delivery Areas (i.e., counties that are served by or adjacent to IHS facilities) and
those that are not.
Our long-term goal is to reduce the burden of cancer among AIAN people by increasing access to
timely, guideline-concordant cancer care. Our current objective is to understand variations in and predictors of
receipt of timely, guideline-concordant cancer care by IHS region, and between PRCDA/non-PRCDA counties.
Our central hypothesis is that there will be substantial variation in receipt of guideline-concordant cancer care
among AIAN people. The rationale for this study is that locally relevant information is essential to support local-
level intervention development in collaboration with AIAN peoples.
To address this objective, this research will pursue two specific aims and one exploratory aim. The first
aim will validate a set of healthcare quality metrics that can be used to assess receipt of timely and evidence-
based services during diagnosis, staging and first-line treatment among AIAN people using only cancer registry
data. We will then use these measures to assess multi-level predictors of timely and guideline-concordant care
among AIAN people across IHS regions using national cancer surveillance data.The second aim will examine
regional differences in predictors of outcomes for leading cancers (breast, lung, colorectal) among AIAN
people, including mediation by receipt of timely and guideline-concordant cancer care. The exploratory aim will
investigate how the associations observed in Aims 1 and 2 vary between AIAN between people living in
Purchased/Referred Care Delivery Areas (i.e., counties that are served by or adjacent to IHS facilities) and
those that are not. This research is innovative because it explores questions about which nothing is known for
AIAN people. Upon the successful completion of this research, we will have elucidated differences in guideline-
concordant cancer care and its relationship with outcomes by IHS region among AIAN people. This information
will provide critical information to understand variation in AIAN cancer disparities that will be used to drive
future healthcare-based structural and programmatic interventions.

Public health relevance
PROJECT NARRATIVE “Understanding regional variation in cancer care delivery and outcomes among American Indian and Alaska Native people” is a one-year study which will use data from the North American Association of Central Cancer Registries Cancer in North America database to examine regional differences in predictors of timely and guideline-concordant cancer care, and cancer survival, among AIAN people. In an exploratory aim, we will also investigate whether these predictors vary between AIAN people living in Purchased/Referred Care Delivery Areas (i.e., counties that are served by or adjacent to IHS facilities) and those that are not. These data will provide critical information to understand causes of AIAN cancer disparities that can be used to drive future structural and programmatic interventions using a local approach, among a population that has often been either excluded from cancer surveillance and health services research for small sample sizes, or treated as one homogeneous population, ignoring known regional heterogeneity.